TIAGABINE HCL MONOTHERAPY IN THE TREATMENT OF PARTIAL SEIZURES

The purpose of this study is to determine the safety and efficacy of two different doses of Tagabine in the treatment of partial seizures when used as the only anti-epileptic drug.